Breast and Ovary Cancers

PROJECT SUMMARY
Cancers of the breast and ovary together account for a high proportion of cancer deaths in women. These
cancers share common themes, including derivation from hormonally responsive tissues, shared genetic
susceptibility, augmented risk based on reproductive behaviors, defects in DNA repair, overlapping molecular
alterations and therapeutic targets, and profound lethality once disease spreads beyond the site of initiation. To
better understand and address these challenges, the Breast & Ovary Cancers Program brings together a cross-
disciplinary and collaborative group of investigators dedicated to reducing the incidence and mortality of breast
and ovary cancers locally, regionally, nationally, and globally. Broadly, we aim to 1) improve strategies to assess
risk, identify, screen, and prevent breast and ovary cancer and 2) develop targeted therapies for breast and
ovary cancers with a special focus on improving response. The program’s 54 members from Fred Hutchinson
Cancer Center and the University of Washington hold more than $20M in research funding, including $5.9M from
NCI. Program members published 751 papers in the current cycle, of which 137 were intraprogrammatic and
180 were interprogrammatic. In response to prior critiques, over the last five years our program has: (i) engaged
with community action boards to enhance the reach of mobile mammography to screen and educate populations
throughout our catchment area, with a special focus on Indigenous populations; (ii) enhanced the basic and
mechanistic expertise of our program through the appointment of a basic and translational research focused co-
leader, by recruiting stellar faculty studying basic mechanisms of breast and ovary cancer therapy resistance,
and by boosting existing research through targeted funding opportunities; (iii) broadened collaboration within and
beyond our program by leveraging Consortium pilot funding opportunities towards the creation of a $25M inter-
institutional endeavor to prevent lethal recurrence. The result of these extensive enhancements is an even more
impactful research program that has more than doubled our NCI funding over the last funding period, enhanced
the reach and impact of our publications reflected by both numbers and the impact metrics, and continued the
conduct of practice-defining clinical studies on a national and international level. Successful execution of our
aims will address incidence and mortality of two lethal cancers that occur within our catchment area (the entire
state of Washington) at higher rates than the national average; reduce disparities in education and access to
diagnostics and care; and produce a pre-eminent program aimed at delivering precision diagnostics and
therapeutics to prevent the incidence and lethality of breast and ovary cancers.